Transient Receptor Potential Melastatin 2 (TRPM2) in Ischemic Stroke

ABSTRACT
Stroke is a leading cause of death and disability worldwide. Over the past few decades, there have been
extensive investigations and enormous research efforts to find better therapies for stroke patients. However,
many strategies that are effective in animal models have proven ineffective in clinical trials. Thus, tissue
plasminogen activator (tPA) is still the only FDA-approved drug for stroke. The lack of successful bench-to-clinic
translation is mainly due to two reasons, with one being the complexity of the pathology of stroke, which includes
a multiplex of signaling pathways, various cell types, and both local and systemic inflammatory responses.
Secondly, the prevailing clinical conditions in patients, such as hyperlipidemia, are not included in animal models
of stroke. We propose that a pleiotropic target which can integrate multiple critical components in various cell
types will be the key to developing effective stroke therapies by using clinically relevant animal models. In this
proposal, we propose that the oxidative stress activated Ca2+-permeable TRPM2 can serve as this pleiotropic
target for developing effective stroke therapies. The goal of this proposal is to investigate whether (Aim 1) and
how (Aim2) TRPM2 plays a vital role in ischemic injury cascade, and to determine whether TRPM2 may serve
as a pleiotropic target for ischemic stroke using the classical stroke model (Aim 1) and a clinically relevant stroke
model (Aim 3). We will use state-of-the-art multidisciplinary approaches to test our hypothesis. Successful
completion of this proposal will not only prove the concept that a pleiotropic target represents a new strategy for
developing effective therapies for ischemic stroke, but also will provide profound insights into translational
implications of developing new stroke treatment by targeting TRPM2.

Public health relevance
PROJECT NARRATIVE Stroke is a leading cause of death and disability worldwide but without effective therapy. We propose that the oxidative stress activated Ca2+-permeable TRPM2 orchestrates ischemia injury cascade by integrating multiple signaling pathways and various cell types at both local as well as systemic levels, and that TRPM2 can be an effective therapeutic target for ischemic stroke. We will use multidisciplinary approaches to delineate the mechanisms by which TRPM2 mediates ischemia injury, and how TRPM2 can be a multimodal target of a holistic therapeutic approach, and our results will provide novel insights into the role of TRPM2 in ischemic brain stroke and may ultimately prove that it is a better target for treatment of ischemic brain stroke.